Impaired Astroglial Glutamate Signaling in Rett Syndrome

ABSTRACT Rett syndrome (RTT) is a leading cause of severe intellectual disability in women. Individuals with RTT develop typically until 6-­18 months, when autism-­like behaviors as well as deficits in purposeful hand use and speech start to develop. Loss-­of-­function mutations in the X-­linked transcriptional regulator methyl-­CpG-­binding protein 2 (MECP2) occur in >95% of RTT cases. Initially, MeCP2 deficiency in neurons was considered as the exclusive cause of RTT, but recent studies have revealed that glial cells lacking functional MeCP2 also have a significant pathological role in RTT etiology. However, specific cellular mechanisms of glial cell dysfunction underlying this role or its behavioral consequences have not been identified. In this study, we propose to examine the contribution of a specific glial subtype, astrocytes, to the dysfunction of the striatum responsible for motor deficits in a Mecp2-­based mouse model for RTT. Astrocytes expressing the Slc1a2 gene encoding glutamate transporter-­1 (GLT-­1, also EAAT2) have a pivotal role in regulating extracellular glutamate levels. We propose to characterize the contribution of GLT-­1 dysfunction to glutamate signaling in conditional knockout (cKO) mice lacking Mecp2 only in astrocytes using a combination of experimental approaches, including whole-­cell intracellular recordings and optogenetics in striatal slices, time-­lapse imaging of intracellular Ca2+ and extracellular glutamate and dopamine, near-­super resolution confocal microscopy, and quantitative behavioral assessments using machine-­learning classifiers. Our preliminary results indicate lower expression levels of Slc1a2 in the striatum of constitutive Mecp2 KO mice, consistent with smaller GLT-­1-­mediated intracellular Na+ signals and membrane currents in striatal astrocytes. Intriguingly, Mecp2 cKO mice show higher locomotor activity in the open field test. We also present preliminary evidence of the role of GLT-­1 in modulating extracellular glutamate levels, intracellular Ca2+ dynamics in astrocytes, and dopamine release from dopaminergic terminals. Based on prior work and these preliminary results, we hypothesize that astroglial glutamate signaling in the striatum is impaired in Mecp2 deficient mice and contributes to their motor deficits. We propose two Specific Aims: (1) Identify and characterize the cellular consequences of GLT-­1 dysfunction in cKO mice lacking Mecp2 in astrocytes, and (2) Characterize neuronal network activity and striatum-­related behaviors in cKO mice lacking Mecp2 in astrocytes. The proposed studies will elucidate the consequences of MeCP2 loss in astrocyte GLT-­1 function on striatum-­dependent behaviors, which will have broad implications not only for RTT but also for other brain disorders associated with striatal dysfunction.

Public health relevance
PROJECT NARRATIVE Rett syndrome (RTT), caused by MECP2 mutations, results from impaired function of neurons and glial cells responsible for proper sensory integration and motor control. As a major glial cell type, astrocytes play a major role in regulating glutamate homeostasis. In this application, we will define the role of MeCP2 in astrocytes of the striatum by characterizing the cellular and behavioral consequences of its conditional cell- specific deletion on astroglial glutamate and dopamine signaling, the function of cortical inputs, and striatum- related behaviors.